NICHD COPPERATIVE MULTICENTER NEONATAL RESEARCH NETWORK

PROJECT SUMMARY
This proposal is a reapplication from the University of Texas Southwestern (UTSW) Medical Center to
participate as a clinical center in the Eunice Kennedy Shriver NICHD Neonatal Research Network (NRN).
Myra Wyckoff, MD became Principal Investigator (PI) in September 2013 and will remain as PI. Luc Brion,
MD and Roy Heyne, MD will continue to serve as Alternate PI and Follow-up PI, respectively. As an NRN
clinical center since 1986, UTSW has the necessary academic, research and clinical infrastructure to
assure continued rigor and reproducibility for NRN studies (Aim 1). UTSW Neonatal-Perinatal Medicine
(NPM) Faculty have broad experience in translational and multi-center, randomized clinical trials with the
NRN and other networks and will contribute to NRN concept proposals, studies, and publications. As an
international leader in newborn resuscitation science, Dr. Wyckoff will provide the NRN with expertise on
issues of perinatal transition, stabilization and resuscitation following birth. Other faculty will bring
expertise in Neuro-Neonatal Intensive Care and hypoxic-ischemic encephalopathy (Dr. Chalak), oxygen
use in the delivery room (Dr. Kapadia), placental effects on the fetus (Dr. Leon), gut microbiome (Dr.
Mirpuri), breast milk and nutritional elements (Dr. Brion), use of clinical informatics for research (Dr.
Lehman) and effects of perinatal interventions on metabolic syndrome and neurodevelopment (Dr.
Heyne). UTSW will work to support trials from a wider range of investigators both within UTSW but also
from investigators outside the core NRN centers (Aim 2) and to leverage resources for wider sharing of
data and biospecimens (Aim 3). The NPM Division has consistent strong support from the UTSW
Pediatric Department as well as its clinical facilities, Parkland Memorial Hospital (PMH), UTSW Clements
University Hospital (CUH) and Children’s Medical Center (CMC) of Dallas. PMH has one of the largest
inborn delivery services in the United States with ~12,000 births per year. CUH has a growing delivery
service with a significant focus on high risk pregnancies and a state-of-the art facility. The CMC NICU is
one of the largest referral units in the region and continues to expand its reach through telemedicine. The
Obstetric Department at UTSW has active referral and research programs across all clinical sites which
ensures that high-risk pregnant women deliver on our campus. The patient population at PMH and CUH
is predominantly under-represented minorities of Hispanic ethnicity and/or Black/African-Americans.
Their inclusion in clinical trials is essential to reduce frequent health disparities (Aim 4). A high percentage
of eligible infants at UTSW clinical sites are enrolled in randomized trials. Protocols are meticulously
followed and complete data is obtained. Follow-up of study infants is integrated within the infant’s primary
medical home at CMC, and follow-up rates are among the highest in the NRN. Thus, UTSW has much
to offer in support of the NRN.

Public health relevance
PROJECT NARRATIVE Public Health Relevance The NRN is designed to perform multi-site interventional trials and observational clinical studies in newborns, particularly low birth weight infants. These studies are designed to improve healthcare and outcomes for high risk newborns and infants.